Use of Tissue Engineered Heart Valves to study Calcific Aortic Valve Disease

Project Summary
Calcific Aortic Valve Disease (CAVD) is the gradual stiffening and calcification of the aortic heart valve, which
serves as a gateway for unidirectional flow of oxygenated blood from the left ventricle to the aorta during each
heartbeat. In severe cases of CAVD, the valve cannot open to allow blood to travel from the heart to the body,
which can cause severe damage to the left ventricle resulting in heart failure and death. Despite its high
prevalence, there are no effective pharmacological therapeutics to date for CAVD, forcing patients to undergo
heart surgery to receive life-saving treatment. We believe that a lack of knowledge about the dynamic stages of
early, mid, and late disease combined with a limited understanding of the heterogenous differentiated diseased
cell populations and the use of in-vitro drug testing platforms that do not capture the full complexity of the disease
contribute to this lack of clinically effective pharmacological therapeutics to date.
To address these critical gaps in the CAVD field, I will first combine our lab’s tissue engineered mechanically
active co-culture valve model with cutting-edge live-OCT imaging to acquire 3D time-lapse images of the
calcification process. Next, I will utilize single-cell sequencing of our tissue-engineered valve model to uncover
characteristics of heterogeneous disease-prone and disease-resistant valvular cells. Finally, I will combine the
information and technologies produced from the first two stages of the project in a multi-dimensional drug testing
platform to investigate when and why a previously discovered pharmacological drug target, NFkB pathway,
reduces calcification in-vitro.
At the conclusion of this project, we will uncover never-before seen time-lapse stages in ECM, cellular
morphology and mineralization changes that are critical for valvular calcification, as well as molecular pathways
related to heterogenous cell groups that are inductive or preventative of calcification. We will utilize these
advancements together to evaluate a promising therapeutic target not just for whether it has an effect, but rather
when and why it has an effect on 3D in-vitro valvular mineralization. The drug-testing platform produced as a
result of this project may be utilized to rigorously evaluate other promising therapeutic targets identified by our
single-cell sequencing results and by other labs, allowing for more rapid and cost-effective evaluation of CAVD
pharmacological therapeutics.

Public health relevance
Project Narrative This project first aims to better understand real-time changes in cells, matrix, and calcification that occur during different stages of calcific aortic valve disease progression in a 3D tissue-engineered valve model, and to uncover heterogeneous cell populations that are prone and resistant to disease. From this information, a multi- dimensional drug-testing platform will be developed and utilized to define how and why inhibition of NFkB pathway utilizing Bay-11 reduces overall calcification. The mechanistic information and drug development platform produced at the conclusion of this project may be further utilized to screen other pharmacological targets, vastly improving the drug-discovery process for this deadly disease that currently has no effective pharmacological treatment.